Administration/Communication Core

Project Summary/Abstract
The Administration/Communication Core (Core A) is responsible for facilitating the coordination and oversight
of all Program activities and for disseminating information within the SPORE and for external interactions. The
Core is designed for low-cost, yet efficient administration and communication in order to focus funds on research
activities. Core A includes a basic science director (Dr. T.-C. Wu) and a clinical research director (Dr. Warner
Huh). Dr. Wu is responsible for coordinating basic scientific efforts and the coordination of individual projects.
Dr. Huh oversees patient identification, enrollment, and patient monitoring in the context of the Core.
The administrative component of the Core follows an organizational diagram for management activities.
Monitoring of research will occur via: 1) Research Project Teams, 2) Committee of Research Project Leaders,
3) Core Investigators Committee, 4) Developmental Research Projects Program, 5) Career Enhancement
Committee, and 6) the central SPORE Steering Committee. Furthermore, the Internal and External Advisory
Boards provide formal evaluations and reports to the Steering Committee. This resource funds a Clinical
Research Coordinator who interacts with the other cores as well as with personnel from each individual project
to ensure that all patient information, specimens, and results are properly collected and recorded in the
computerized database. Core A also funds patient advocate(s), who provide invaluable feedback on various
SPORE activities from a unique perspective. Appropriate monitoring of patient safety, adverse events, and data
management and confidentiality will be provided by the data safety monitoring boards. The communication
component of the Core is directed at intra-SPORE, inter-SPORE, and National Cancer Institute research
activities. The Core coordinates essential Program interactions including preparing applications and progress
reports for the SPORE, all planning and evaluation activities, arranging and publicizing SPORE activities,
coordinating advisory committee meetings, producing annual reports and performing analysis of budgetary
matters.

Public health relevance
Project Narrative The Administrative/Communication Core (Core A) aims to facilitate coordination and oversight of all program activities of the Cervical Cancer SPORE Program. Core A coordinates essential Program interactions, including preparing applications and progress reports for the SPORE, all planning and evaluation activities, arranging and publicizing SPORE activities, coordinating advisory committee meetings, producing annual reports and performing analysis of budgetary matters. Core A will also facilitate communication within the SPORE, between the SPORE and other entities, and with the National Cancer Institute.